Molecular mechanism of ABHD6 enzymatic activity in neurons

Summary The most abundant endocannabinoids (eCB) in brain, 2-arachidonoyl glycerol (2-AG), is inactivated by two distinct enzymes: monoacylglycerol lipase (MAGL) and ????hydrolase domain-contain 6 (ABHD6). The selective inhibition of these enzymes increases the net levels of 2-AG in different neuronal compartments, presynaptic and postsynaptic, respectively. Accordingly, selective inhibition of these enzymes induces different spatiotemporal enhancement of 2-AG signaling and distinct or synergistic therapeutic benefits. We recently gathered results showing that ABHD6 hydrolyzes additional monoacylglycerol substrates than 2- AG and that ABHD6 inhibitors increase the net levels of 2-AG only in highly activity neurons, suggesting a novel molecular mechanism. To increase our mechanistic understanding of ABHD6 at the structural and atomic levels, we initiated an effort and have now successfully purified several functional ABHD6 protein constructs ready for structural analysis. Based on this premise, we propose the following two aims that will determine the: Aim 1: Molecular mechanisms of ABHD6 enzymatic activity. Aim 2: Structure function relationship of ABHD6. Completion of the work outline in this new R21 grant proposal will provide a comprehensive understanding of the role of ABHD6 in controlling eCB signaling in brain within the context of neurological diseases. Our long-term goal is to increase our understanding of the role played by ABHD6 in healthy and diseased brain and help develop novel therapeutics that lack the potential for abuse and adverse effects produced by classic cannabinoid agonists.

Public health relevance
Project Narrative Small molecules that target the endocannabinoid (eCB) signaling system in brain are powerful tools to discover the basic biological function of this signaling system and represent promising therapeutics to treat neurological diseases. Here we will use innovative genetic tools and molecular reagents to study how the eCB hydrolyzing enzyme, hydrolase domain-contain 6 (ABHD6), regulates the signaling of 2-arachidonoyl glycerol (2-AG), the most abundant eCB in brain. This research will provide a comprehensive understanding of mechanism of action and atomic structural components of ABHD6 that control 2-AG signaling in brain within the context of neurological diseases, with the potential of developing novel therapeutics that will benefit patients while avoiding the abuse liability and adverse effects produced by cannabinoid agonists.